Role chemoattractant receptors in inflammatory aspects of neurodegenerative Dise

We have found that the receptor FPRL1 recognizes Alzheimer's disease-associated amyloid beta peptides and promotes proinflammatory responses in the brain. We used mouse FPRL1 counterpart mFPR2 as a model for further understanding of the receptor in the progression of the disease. We found that mFPR2 in microglial cells, the macrophages in the brain, is upregulated by diverse proinflammatory stimulants, including agonists for the pattern recognition receptors and cytokines. Increased expression of mFPR2 on microglial cells enhances the capacity of the cells to endocytose amyloid beta peptide, therefore the receptor may profoundly affect the progression of the disease.